CALCIUM BALANCE BONE MINERAL CONTENT AND NEONATE SKELETAL GROWTH WITH BPD

To demonstrate interactions that occur between the hormones related to calcium metabolism in the premature neonate. Nutritional and metabolic profiles of infants with bronchopulmonary dysplasia receiving a calcium supplemented diet will be compared to healthy preterm infants examining calcium balance, bone mineral content and biochemical parameters.